SHORT TERM CANCER RESEARCH EXPERIENCES

This application for a R25 Cancer Education Grant describes a major project within the overall cancer education program of the University of Colorado Cancer Center, namely the Cancer Student Research Assistant Program which offers short-term cancer-related research experiences for medical, dental, nursing, and pharmacy students, college undergraduates, and high school seniors. Special efforts are made to attract under- represented minority students to the program. Approximately 125 potential research opportunities are available each summer, each with an experienced, funded investigator. A centralized, coordinated application, selection, and evaluation process is described. The aims of this program are to promote interest among high school, college, and health professional school students throughout the region in order to prepare them for subsequent on-campus assistantships; to evaluate the program; and to disseminate information concerning the program to the cancer-education community. Because there have consistently been far more applicants then can be funded in past years, a plan is underway to obtain or develop cancer education materials which can be provided through the Internet to students in their home communities, thereby seeking to prepare them to quality for on-campus research assistantships in subsequent summers. A team of experts in cancer education content, educational design, Worldwide-Web-based educational technology, and educational evaluation is available to extend the successful on-campus student research program to students in their home communities, again emphasizing minority students, in a pilot project which will employ institutional resources with limited augmentation from this grant.